Shifting paradigms to emerging toxins in freshwater cyanobacterial blooms

PROJECT SUMMARY
Cyanobacterial harmful algal blooms (cyanoHABs) and the toxic compounds produced during these events have
become a persistent problem in freshwater systems and have affected local populations by contaminating
drinking water and placing a significant burden on local economies due to diminished recreational activity.
Microcystins, generally the dominant class of toxins in cyanoHABs, primarily affect the liver (hepatotoxin), but
have been described to also affect the kidney, the reproductive system, and the brain. Cyanobacteria in these
bloom events are known to produce a suite of hepatotoxins in addition to the microcystins such as the
cylindrospermopsins, and alkaloid neurotoxins such as saxitoxin and anatoxin. Preliminary results from the Bertin
Laboratory and collaborative industry partners in the proposed project, Biosortia Pharmaceuticals, have shown
exquisitely potent cytotoxins exist in environmental collections of cyanobacterial biomass harvested from inland
lakes and water bodies. A suite of these emerging compounds (steroidal lactones) departs significantly from the
types of toxic compounds typically associated with these bloom events (peptidic and alkaloidal toxins). These
newly discovered compounds are significantly more potent than microcystin-LR and have never been previously
described from cyanoHAB events. Thus, there is a significant and unmet need to understand the production of
these compounds and other cytotoxic metabolites during cyanoHABs and to develop detection, isolation, and
toxicological evaluation tools that can be utilized by natural resource management agencies and inform public
health policy makers. Furthermore, preliminary results indicate that there are new microcystins in cyanoHABs
that are significantly more cytotoxic than any of the 130 known microcystin congeners. The rationale of this
research project is that there needs to be a full accounting of the toxic chemical space present in cyanoHABs.
Furthermore, the diversity of multiple toxic compounds requires new evaluation tools to determine the most
potent cyanotoxins, their mode of action, and their potential toxicity on the liver and how that relates to systemic
injury. Project goals will consist of the identification and isolation of emerging toxic compounds using
metabolomics approaches, microbial community analysis, and the structure elucidation of emerging toxins (Aim
1). Furthermore, the toxin composition of cyanoHABs will be investigated in a time course study to provide
temporal resolution with respect to toxic metabolite composition (Aim 1). Next, a toxicological assessment will
be used that integrates in silico, in vitro, and proteomic studies to determine toxicity and the mechanism of action
of toxins (Aim 2). Instrumentation and expertise are in place for project success. This project will result in the
isolation and characterization of emerging toxins and significantly departs from the current status quo of focusing
on microcystins. Additionally, this work will develop an understanding of the mechanistic toxicity of these novel
emerging metabolites to potential liver injury, which can be an early mediator of systemic disease.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because the range and impact of cyanobacterial harmful algal blooms (cyanoHABs) in freshwater systems is expected to increase as the climate changes, which will potentially exacerbate its role as a vector for human exposures and hepatotoxic events. Thus, the proposed research is relevant to the broad NIH mission of discovering how a changing environment will affect public health. Additionally, this work will define new emerging toxins from cyanoHABs and their toxicology with respect to the liver. While many cyanoHAB toxins are known to affect the liver, the maladies they can cause, such as nonalcoholic fatty liver disease, are early mediators of systemic disease.